Research Bronchoscopy and Biospecimens Core

PROJECT SUMMARY/ABSTRACT
Core B: Bronchoscopy and Biospecimens
The goal of this core is four-fold. First, the core is responsible for performing bronchoscopy on study subjects
to obtain all the necessary lung specimens for in vitro experiments. This includes collecting all the
appropriate control specimens at the time of study. Second, the core is responsible for processing
specimens in such a way that they can either be used real time or stored appropriately for future use. This
includes coordination of processing and storage protocols between labs. Third, the core is responsible for
aliquoting samples in appropriate sizes and conditions (i.e. RNA preservation media, DMSO) for storage in
appropriate environments (i.e. -80o freezer, liquid nitrogen) for future studies. Finally, the core is responsible
for labeling and tracking all specimens, including the linkage of specimens to subject metadata. By providing
uniform specimens to all investigators the core can ensure interdisciplinary integration of the multiple projects
that make up the combined Program Project.